Dopamine modulation of the neostriatal feedback circuitry

[unreadable] DESCRIPTION (provided by applicant): GABAergic inhibition is a primary determinant of the activity of neostriatal projection neurons and recent evidence demonstrates that a significant fraction of this inhibitory control originates from the axon collaterals of the projection neurons themselves. The existence of a functional synaptic circuitry among projection neurons suggests a critical role in the regulation of the spatial and temporal pattern of activity of the neostriatum, and in particular in the control of the balance of activity between the functionally segregated output pathways (the "direct" and "indirect" pathways) of the neostriatum. To extend the understanding of the inhibitory circuitry of neostriatal projection neurons the first objective of the present proposal will be to investigate the connectivity and the biophysical properties of synaptic communication between the striato- nigral (direct) and striato-pallidal (indirect) neostriatal projection neurons with paired whole cell voltage and current clamp recordings in acute brain slices . The second major objective is to test the hypothesis that dopamine regulates synaptic transmission among projection neurons in a circuit dependent manner through two different receptor mechanisms. Our preliminary data demonstrate that synaptic transmission between a subset of pairs of projection neurons is enhanced by dopamine through D1-like receptors while D2-like receptors suppress transmission between a complementary population of pairs. Considering the strict segregation of the two mechanisms demonstrated by our preliminary data, and the known projection pathway selective distribution of dopamine receptors, we hypothesize that the feedback circuitry of projection neurons contributes to the dopaminergic control of the relative activity of the direct and indirect pathways through differential modulation of synaptic connections of projection neurons of the two neostriatal output pathways. These questions will be investigated in electrophysiological and pharmacological experiments by obtaining in vitro paired recordings from projection neurons identified using single-cell RT-PCR profiling of the expression of enkephalin, substance P and the 5 main dopamine receptor subtypes. The basic cellular mechanisms responsible for the differential regulation of activity of the opponent output pathways of the neostriatum has important implications for the understanding of the pathophysiology of several neurological and psychiatric disorders including Parkinson's and Huntington's disease, schizophrenia and drug addiction. In particular, understanding the dopaminergic modulation of the neostriatal circuitry may facilitate the identification of novel, non-dopaminergic primary or adjunctive pharmacotherapies of Parkinson's disease and contribute to the improvement of non-pharmacological treatment modalities of the disorder. [unreadable] [unreadable] [unreadable]